IGF::OT::IGF HHSN261201600007I/HHSN26100001, POP 03/01/2016 - 02/28/2017, PRIMARY PRODUCT/SERVICE CODE TO: B537, DESCRIPTION: CENTRAL DATA COLLECTION CENTER (CDCC), WESTAT

The purpose of this contract is to increase the value of the Prostate, Lung, Colorectal and Ovarian (PLCO) Cancer Screening Trial (PLCO) and National Lung Screening Trial (NLST) resources by: 1) continuing the follow-up of participants for an additional 5-year period (2016-2021); 2) updating key exposure data and collecting additional data; 3) collecting additional clinical data; 4) substantially increasing the number of accrued incident cancer; 5) strengthening the trials’ abilities to evaluate the long-term effects of screening on cancer mortality; and, 6) allowing for a continued opportunity to collect additional exposure data and/or biospecimens.